Understanding the long term impact of COVID-19 on the brain through advanced MR imaging and spectroscopy

PROJECT SUMMARY/ABSTRACT
Since the World Health Organization declared COVID-19 a pandemic in March 2020, increasing
evidence has shown that the disease affects multiple organs, including the central nervous system (CNS). The
COVID BRain Advanced Imaging Network (COVID-BRAIN) was formed to elucidate the long-term CNS
pathophysiology of COVID-19 systematically and prospectively. We use highly sensitive, harmonized,
advanced MR technology at 3 tesla to interrogate neuroinflammation, neurodegeneration and cerebrovascular
disease in individuals with persistent neurological sequalae following SARS-CoV-2 infection. Five sites that
also partner in other multi-site neuroimaging initiatives (University of Minnesota, Mayo Clinic Rochester,
Harvard University/Massachusetts General Hospital, Johns Hopkins University, Houston Methodist Research
Institute) collect longitudinal multi-modal MRI (T1, FLAIR, diffusion MRI, susceptibility-weighted MRI, single-
and multi-voxel MR spectroscopy and pseudo-continuous arterial spin labeling), clinical, neurocognitive and
inflammatory blood biomarker data from laboratory confirmed post-COVID cases with neurological symptoms
and matched controls.
The pathophysiologic components of CNS injury associated with COVID-19 can potentially lead to
increased risk for Alzheimer’s disease and its related dementias (AD/ADRD) as emphasized in the 2022 ADRD
Summit recommendations. Therefore, in Aim 1, we will assess AD/ADRD risk in patients with long-COVID
using blood-based biomarkers (Abeta 1-40, Abeta 1-42, pTau181, NfL and GFAP) and determine whether
APOE ε4 status, age, sex, race, ethnicity, and social determinants of health modify this risk. In Aim 2, we will
investigate the associations of these blood-based biomarkers with MRI/MRS markers of neuroimflammation,
neurodegeneration and cerebrovascular disease in patients with long-COVID and whether APOE ε4 status,
age, sex, race, ethnicity, and social determinants of health modify these associations.
The insights provided by this study will be critical for developing disease-modifying therapies targeting
the underlying pathologic mechanisms associated with the long-term CNS consequences of COVID-19,
including increased risk for AD/ADRD.

Public health relevance
PROJECT NARRATIVE The overall goal of this project is to understand the long-term effects of COVID-19 on the brain, by using advanced, quantitative imaging technology in a multi-institutional collaboration. COVID-19 can potentially lead to increased risk for Alzheimer's disease and its related dementias (AD/ADRD). In this supplement, we request funds to add blood-based markers of AD/ADRD risk to our study protocol and to enhance our outreach efforts to communities who have been disproportionately affected by both COVID-19 and AD/ADRD. With these funds we will determine if markers of AD/ADRD risk are elevated in blood of individuals who have persistent neurological symptoms after COVID-19 and if these markers are associated with neuroimaging measures of AD/ADRD related pathology in the brain.